Bunyavirus and Picornavirus Pandemic Pathogen Preparedness (BP4) Center

Project Summary
Pathogenic picornaviruses and bunyaviruses have an enormous impact on public health worldwide, and our
understanding of mechanistic correlates of immunity for members of these virus families is limited. Because of
the diversity of viruses in these families, it is unlikely medical countermeasures (such as vaccines and antibodies)
can be developed ahead of time for each one of these viruses, therefore a prototype pathogens approach is
warranted. We have assembled a highly interdisciplinary consortium of leading investigators in the field of
picornavirus and bunyavirus virology, immunology, vaccine biology and antibody sciences to study the
mechanistic correlates of immunity to prototype pathogens for these families, and then apply the principles we
learn with the prototype pathogens to different pathogenic viruses in those families that are antigenically distinct.
All five Research Projects (RP) in the Center focus on developing strategies effective against all pathogenic
members of a group of viruses, picornaviruses, hantaviruses, and diverse arenaviruses. RP1 focuses on
innovative vaccine strategies for picornaviruses (enterovirus D68, enterovirus A71, echovirus 11 and rhinovirus
C types), RP2 focuses on human anti-picornavirus monoclonal antibodies, RP3 focuses on novel vaccine
candidates for hantaviruses, RP4 focuses on human mAbs for Sin Nombre, Andes and Hantaan hantaviruses,
and RP5 proposes studies on arenavirus vaccines and antibodies, with LCMV as an initial prototype for study.
A unique aspect of this Center is that it includes full complementary research projects for both vaccine and mAbs,
which are the two most well-studied countermeasures that provide complete pre- or post-exposure protection
against virus infections. The advanced level of certain preliminary findings in the work described in the RPs is a
major strength and advantage of our Center. There has relatively little significant progress over the last decade
in the development of vaccines or postexposure therapies for picornaviruses or bunyaviruses. Preventive
vaccines would have utility for the public during local or large-scale outbreaks, for laboratory workers, for first
responders or individuals at high-risk exposure, and for certain travelers or military personnel. In the case of a
biological attack or natural outbreak, however, a preventative or postexposure antibody treatment would be the
most practical approach for rapid deployment and has the advantage that antibodies can be used in any age or
health condition, including the immunocompromised. perform pivotal studies that will facilitate the development
of products used for the prevention and treatment of Nipah and Hendra infections. The cooperation among the
paired vaccine + mAb RPs, the Administrative Core, the sample acquisition, structural biology, and vaccine
technology cores is built into the Center by design, as all components work together to provide broadly effective
candidate countermeasures. Quality system data management will be employed in both the preparation of
advanced stage test articles and in the conduct of animal studies.

Public health relevance
PROJECT NARRATIVE The BP4 consortium brings together experts in virology, immunology, vaccine sciences, and antibody discovery to perform advanced research on prototype pathogens for Picornaviruses and Bunyaviruses. The group will develop both protective antiviral human antibodies (passive immunity) and vaccines (active immunity) for each of the viral pathogens studied. The highly interactive consortium will leverage lessons learned in the antibody studies of sites of vulnerability on the viruses to develop and test new vaccine concepts that can be extended from one prototype pathogen to all members of that class of viruses.